Analytical Biochemistry Shared Resource

This facility, operating since 1990, provides cost-effective and accurate chemical analyses for molecules relevant to cancer research of Cancer Center (CC) investigators. It is also a base for consultation related to the quantitation of analytes and strategies in analytical chemistry. Services and expertise in advanced methods are available including state-of-the-art techniques, particularly liquid chromatography mass spectrometry (LCMS) and multiplexed immunoassays. In addition, routine analyses and determinations of clinical markers are offered to investigators. A host of new assays have been implemented in the current cycle due to needs of CC members. No other laboratories are available to provide many of these services in the State of Hawai'i, particularly regarding type, speed, cost, and combinations of assays, many of which are custom designed by this core to fulfill the specific requirements of CC projects. The high quality of services is continually monitored by taking part in internal and external quality assurance programs including the participation in round robin tests organized by the National Institute of Standards and Technology. The availability of this core provides state-of-the-art services, improves feedback to the investigators, stimulates inter-disciplinary collaborations, and provides cost effective service to CC investigators. The current use at full capacity is anticipated to continue for the foreseeable future. Newly funded projects requiring services of the resource will outnumber projects terminating in the coming years. Equipment obtained through the CCSG support grant in the current cycle has greatly enhanced the potential of this resource. This facility has shown remarkable growth: its productivity increased by 84% since the last cycle and has grown accordingly in personnel and revenue. The great value of this core is underscored by a total of 79 cancer related peer reviewed publications during FY06-11 that involved services by the ABSR (58% inter-programmatic, 13% intra-programmatic).

Public health relevance
The Analytical Biochemistry Shared Resource (ABSR) contributes to the research activities of the Cancer Center in many important ways. The ABSR is cost-effective, fast and accurate in addition to being flexible regarding Center needs, and provides the quantitative molecular data critical to multiple NCI-funded projects.